Optimizing HCT Outcomes: A Multi-omic Investigation

ABSTRACT
Hematopoietic stem cell transplantation (HCT) is an essential treatment for high-risk non-malignant and
malignant hematologic diseases. However, outcomes remain inadequate, with multiple immune-mediated
complications contributing to mortality. With 5-yr survival often <60%, there is an urgent need to improve
results. We will address this by deciphering the mechanisms driving HCT outcomes by studying the biology of
HCT patients at a depth and scale not previously achieved. To accomplish this, we have partnered with the
Blood and Marrow Transplant Clinical Trials Network (BMT CTN), the NMDP, and the Pediatric Transplant
Consortium (PTCTC) to perform detailed biologic studies on patients with both non-malignant and malignant
hematologic diseases enrolled on multicenter HCT trials. Our goal is to leverage the power of systems
immunology, genomics, and state-of-the-art microbiome analysis to determine, from patient samples, the
underlying mechanisms that drive clinical transplant outcomes. We will do so through the following Aims: Aim
1: The Tradeoff Between T Cell Reconstitution and GVHD: Optimizing Immunomodulation to Optimize
Transplant Outcomes. In this Aim, we will test the hypothesis that a GVHD prophylaxis strategy can be
identified that improves immune reconstitution compared to PT-Cy (50mg/kg), while still controlling GVHD. Aim
2: The Host:Microbe Dyad and Its Influence on Transplant Outcomes. In this Aim, we will test the
hypothesis that microbiome dynamics at the taxonomic and subtaxonomic (strain) level, driven by conditioning
regimen and GVHD prophylaxis choice, are predictive of (a) pathogen domination and infectious complications
of HCT, (b) gut GVHD, and (c) immune reconstitution. Aim 3: Cellular and Molecular Analysis To Predict
Relapse and Graft Failure: In this Aim, we will examine the interface of immune reconstitution and both
relapse and graft failure. This proposal seeks to create a new paradigm for transplant trials: an integrated,
embedded scientific hub that can efficiently collaborate across multicenter clinical trial organizations to address
the most pressing biologic questions linked to patient outcomes. If successful, it will lead to the discovery of
biologic mechanisms driving HCT results, such that fully safe and effective transplant approaches can be
developed.

Public health relevance
PROJECT NARRATIVE Hematopoietic stem cell transplantation (HCT) is an essential treatment for high-risk non-malignant and malignant hematologic diseases, but outcomes remain inadequate, with multiple immune-mediated complications contributing to mortality, and with 5-yr survival often <60%. The goal of this application is to leverage the power of systems immunology, genomics, and state-of-the-art microbiome analysis to determine, from patient samples, the underlying mechanisms that drive clinical transplant outcomes. The proposed research is highly relevant to public health because it aims to improve survival for patients that are undergoing HCT, by discovering underlying mechanisms that can lead to the creation of optimal treatment paradigms.